Effects of SARS-CoV-2 Antiviral Ribonucleoside Analogues on Mitochondrial DNA

PROJECT SUMMARY
Antiviral nucleoside analogues are a type of broad-spectrum medication used to prevent viral replication. Only
one FDA approved treatment for COVID-19 is a nucleoside analogue and was used under FDA emergency
directive to reduce hospitalization times to treat patients infected with the SARS-CoV-2. However, in the past,
FDA approved antiviral ribonucleoside analogues used to control infection during the US HIV/AIDS epidemic
were shown years later to cause mitochondrial DNA mutations, mitochondrial dysfunction, myopathies, and
cause chronic side effects to treated patients. This proposal addresses whether these novel antiviral
ribonucleoside analogues (Remdesivir) currently the only FDA approved mediation or (N4-Hydroxycytidine) in
Phase II/III clinical trials for COVID-19 affect mitochondrial DNA and mitochondrial function causing cellular and
tissue dysfunction. This proposal will use NextGen sequencing, biochemical approaches, mitochondrial assays,
and preclinical rodent models of different strains, sexes, and ages to address the following aims. Aim 1:
Characterize mtDNA alterations and consequences to OXPHOS function after exposure to a panel of antiviral
ribonucleoside analogues. Aim 2: Determine if antiviral ribonucleoside analogues differentially affect
mitochondrial function in aged physiology. Even though vaccines are now available for COVID-19, vaccine
hesitancy and the appearance of more transmissible SARS-CoV-2 strains are an emerging threat. Also, antiviral
nucleoside analogues are often recycled for new viral infections as in the case of Remdesivir which was initially
developed against Hepatitis C. This means that these medications may be reused in future viral infections. The
research and medical community needs to know whether these antiviral ribonucleoside analogues have off-
target side effects, so physicians will be able to make better informed decisions on the costs and benefits of
these type of medications for their patients.

Public health relevance
PROJECT NARATIVE Newly developed antiviral ribonucleoside analogues are currently the only FDA approved medications used to treat COVID-19 patients. Other types of antiviral analogues in the past have been shown to cause mitochondrial DNA mutations and damage mitochondria causing unwanted side effects and chronic tissue damage to patients. This project aims to evaluate if these novel antivirals used to treat COVID-19 patients damage mitochondrial DNA and perturb mitochondrial function to better inform researchers and physicians of their safety profile.